Safety, tolerability &pharmacokinetics of SDZ RAD in de novo liver transplant

A one-year multi-center randomized, placebo controlled double-blind, parallel, group, dose finding study to evaluate the safety, tolerability and pharmacokinetics of rad001 in de novo liver transplant recipients (cradoo1B158)"